HEMODYNAMIC AND HORMONAL CHANGES OF EARLY NORMAL HUMAN PREGNANCY

Normal healthy women are being evaluated during pregnancy and a normal menstrual cycle by non-invasive means and periodic blood and urine sampling to better understand early cardiovascular and renal changes which accompany normal pregnancy.